Project 1: Lung Cancer

PROJECT 1: PROJECT SUMMARY
Lung cancer remains the leading cause of cancer mortality in the United States (U.S.) with a projected estimate
of 228,820 new cases and 135,720 deaths from lung cancer in 2020. Nationally, non-Hispanic African
American/Black (AA/Black) men have a disproportionately higher incidence and rate of death from lung cancer
compared to their non-Hispanic White (White) male counterparts; however, no such lung cancer disparities exist
between AA/Black and white women nationally. Notably the increased rates of lung cancer mortality seen in
AA/Blacks relative to their white male counterparts appears to be independent of smoking duration, intensity,
quit years, and socioecominc status. Moreover, the underlying molecular mechanisms that contribute to
increased lung cancer in AA/Black men remains to be fully elucidated. These disparities are likely driven by a
complex and poorly understood interaction between inequities in access care, segregation, upstream
determinants of health, chronic exposure to community stress, tobacco exposure, and molecular oncogenic
drivers. Epigenetic regulation drives normal cellular growth and development, and the deregulation of epigenetic
processes are certainly observed in lung cancer. However, epigenetic-based therapeutic targeting in cancers
using DNA hypomethylating agents have largely been unsuccessful in clinical trials. Understanding the
epigenetic processes associated with increased cancer development and growth can uncover social and
biophysical mechanisms of lung cancer contributing to the current lung cancer disparity in AA/Black men. We
have identified protein arginine methylation as a potentially exciting novel lung cancer biomarker and potential
drug target, protein arginine methyl transferases 6 (PRMT6). We have determined that 1) PRMT6 expression is
increased in AA/Black men; 2) smoking stimulates PRMT6 expression; and 3) PRMT6 overexpression in an in
vivo model drives lung tumor development. We hypothesize that the combined effects of community stress and
smoking in AA/Black men may be contributing to the AA/Black male “Smoking Paradox” and that PRMT6 may
serve as a suitable biomarker capturing these combined exposures (i.e. community stress and smoking) with
the potential benefit of enhancing early detection of lung cancer in AA/Black men. TRACER Project 1 aims to
measure the interaction between the “community-ome” and the molecular determinants of lung cancer to better
define the risks among AA/Black men. Gaining a better understanding of PRMT6 and its role as a molecular
biomarker will be an important first step to establishing this innovative approach. Project 1 will lay the foundation
for a future full SPORE to enhance the identification and screening accuracy for AA/Black men at risk for lung
cancer. As such, it has become clear that the addition of molecular biomarkers, e.g. PRMT6 among others, could
potentially improve the effectiveness of LCa screening. The findings from the proposed studies are expected to
not only make significant contributions to the basic understanding of lung cancer health disparities in AA/Black
men, but also assist in developing novel biomarkers for early detection of lung cancer in AA/Black men.

Public health relevance
PROJECT 1: PROJECT NARRATIVE TRACER Project 1 aims to measure the interaction between the “community-ome” and the molecular determinants of lung cancer to better define the risks among African American (AA(/Black men. The findings from the proposed studies are expected to not only make significant contributions to the basic understanding of lung cancer health disparities in AA/Black men, but also assist in developing novel biomarkers for early detection of lung cancer in AA/Black men. The proposed innovation and translational impact of this project will ultimately be to include both molecular and community markers (e.g. neighborhood violence, poverty, along with individual- level allostatic load ) to better define and stratify at risk AA/Black men with lung cancer.